Pregnancy/NO Induced Changes in UAE Ca2+Signaling

DESCRIPTION (provided by applicant): Preeclampsia (PE) adversely affects as many as 20% of pregnancies in the USA. One of the earliest events is the failure of maternal vascular endothelium vasodilatory function to adapt, with the normal pregnancy-associated increase in NO being blunted or lost. In our previous funding period we used dual imaging of [Ca2+]i and NO in freshly isolated uterine artery endothelium to show that in normal pregnancy, enhancement of Ca2+ signaling is the primary cause of enhanced NO production, and such enhancement depends on specific changes in function of Ca2+ signaling mediators. Sustained Ca2+ entry into UA endothelium occurs through TRPC channels but our preliminary data also suggests the pregnancy enhanced opening of TRPC channels in turn depends on CX43 Gap junction communication, and that such coupling of cells may occur at an electrical level. Our data further suggests membrane hyperpolarization by KCa type channels connects increased Gap junction function to enhance TRPC function in pregnancy. Consistent with this, UAEC show sensitivity to antagonists of KCa function (Apamin and Tram34) with a resulting reduction in Ca2+ signaling. If this model is correct then future therapy for failed adaptation of Ca2+ signaling in PE pregnancy could be achieved by the use of SK or IK type KCa channel agonists. In this renewal we propose to test this model, moving from isolated cells in culture to whole vessels ex vivo to whole animal studies. We will examine 1) Changes in membrane potential and KCa current activity in response to ATP in NP- and P-UAEC in cells at low vs high density, dependence of these changes on gap junction function, and determine the effect of antagonists Apamin and Tram-34 or the selective agonist NS309 on Ca2+ burst activity to implicate KCa channels in this response; 2) Examine the effects of these same antagonists and agonists on changes in Ca2+, membrane potential and NO production in intact UA vessels ex vivo; 3) determine if the KCa agonist NS309 is comparable to the effects of ATP/UTP in mediating NO dependent increases in blood flow in uterine artery in vivo during pregnancy, and also the extent to which SK and/or IK types of KCa channel mediate this effect. In this way we take our recent advances in mechanistic knowledge of pregnancy adaptation of blood flow to now establish the validity of using KCa channel agonists to maximize this response in vivo in pregnancy and particularly those complicated by PE. Success could have major impact on strategies to improve treatment of human PE pregnancy where this otherwise normal adaptive response has failed and is resistant to current therapies.

Public health relevance
PUBLIC HEALTH RELEVANCE: Preeclampsia (PE) is a potentially devastating disease of pregnancy that can threaten the life of both mother and the unborn child. It affects as many as 20% of the population. Even mild PE is dangerous and can cause preterm (early) birth and this then gives the baby an increased risk to develop several diseases such as blood pressure, diabetes and obesity as an adult. It is believed that in PE the cells lining the uterine artery blood vessels fail to increase their function as would otherwise happen in normal pregnancy. We have evidence to suggest normal adaptation is due to electrical changes and their failure may be 'fixed' with a specific drug NS309. The aim of this project is to find out if our suspicions are correct by testing in an animal model. If we are right we may be able to come up with a treatment plan fro PE pregnancy. Having more complete knowledge of how cell function is regulated in pregnancy will certainly take us one step closer to overcoming this potentially devastating disease that effects so many in this country and beyond. Public Health Relevance Statement: Preeclampsia (PE) is a potentially devastating disease of pregnancy that can threaten the life of both mother and the unborn child. It affects as many as 20% of the population. Even mild PE is dangerous and can cause preterm (early) birth and this then gives the baby an increased risk to develop several diseases such as blood pressure, diabetes and obesity as an adult. It is believed that in PE the cells lining the uterine artery blood vessels fail to increase their function as would otherwise happen in normal pregnancy. We have evidence to suggest normal adaptation is due to electrical changes and their failure may be 'fixed' with a specific drug NS309. The aim of this project is to find out if our suspicions are correct by testing in an animal model. If we are right we may be able to come up with a treatment plan fro PE pregnancy. Having more complete knowledge of how cell function is regulated in pregnancy will certainly take us one step closer to overcoming this potentially devastating disease that effects so many in this country and beyond. __SpecificAimsTextDelimiter__ SPECIFIC AIMS: Maternal adaptation to pregnancy is characterized in part by a profound increase in endothelium-mediated vasodilation in the uterine artery, and conditions such as preeclampsia (PE) which result in reduced uterine perfusion and a failure of this response. In the prior funding period we have shown that differences in UA endothelial cell activation during normal pregnancy relate to an increase capacitative Ca2+ entry (CCE) that is mediated by TRPC3/IP3R2 activation, and is comprised in individual cells of a series of [Ca2+]i bursts. Pregnancy increases both number of bursts per cell and the number of cells that repeatedly (and synchronously) burst, and is very much dependent on pregnancy enhanced communication between cells via CX43 Gap junctions. The activation of eNOS is greatly dependent on this process, and any inhibition of pregnancy enhanced [Ca2+]i bursts (2-APB, U73122, or Gap junction inhibitors) correspondingly reduces eNOS activation specifically to NP levels. We have also shown that VEGF165, a growth factor elevated in the placenta of preeclamptic women, can promote phosphorylation and closure of CX43 in UA Endo, again with similar associated loss of Ca2+ bursts and NO production. While therapeutic targeting of CX43 may be tempting, it is impractical since CX43 also plays a role in contractions of myometrium and so treatment Abbreviations: NP-Nonpregnant; P- Pregnant; UA Endo-Uterine Artery Endothelium; UAEC- Uterine Artery Endothelial Cell (passage 4-5); NO-nitric oxide; eNOS-endothelial nitric oxide synthase; VSM-vascular smooth muscle. P2X-ion channel ATP receptors, P2Y-G protein coupled ATP receptors. [Ca2+]i; intracellular concentration free Ca2+ ion; TRPC-Transient Receptor Potential Channel Type C; L-Channels- subtype of voltage sensitive Ca2+ channel. IP3-R-Inositol Trisphosphate Receptor; PLC-phospholipase C; CX43- Connexin 43 Gap junction protein. KCa-[Ca2+]i sensitive K+ channel; BK/SK/IK- subclasses of KCa channel. PE-Preeclampsia; IUGR-Intrauterine Growth Retardation; MAP-Mean Arterial Pressure; UBF-Uterine blood flow. may precipitate labor. The unique role of TRPC3/IP3R2 in endothelial cell [Ca2+]i signaling may provide a better/more viable target for endothelial therapy in PE women where it may otherwise have failed, since the TRPC3 dependent mechanism in UAEC is different from the voltage sensitive Ca2+ channels employed in smooth muscle cells of UA VSM or myometrium. A problem is we do not have agonists specific to TRPC3 channels. Nonetheless TRPC3 opening probability is also influenced by membrane potential, and CX43 coupling of endothelial cells is known to directly effect changes in membrane potential. Many endothelial cells also express [Ca2+]i activated K+ hyperpolarizing channels (KCa) of small and intermediate conductance (SK and IK, respectively) which on activation by a small elevation of [Ca2+]i could potentiate hyperpolarization further, so causing rapid TRPC3 channel opening and a [Ca2+]i 'burst'. Our preliminary data suggests SK/IK channels do indeed play a role in coupling pregnancy enhanced Gap junction function to enhanced [Ca2+]i bursts in P-UAEC, and we further propose that when cell-cell coupling is otherwise lost due to Gap Junction inhibition, direct activation of SK and/or IK type KCa channels using NS309 may restore function. This unifying hypothesis not only explains pregnancy enhanced [Ca2+]i bursts, but also provides a specific target for therapy (SK/IK channels), since the unique action of agents enhancing [Ca2+]i bursts on endothelial cells would not have unwanted side effects on UA VSM or myometrium. To that end, we plan to establish the electrophysiology of NP- and P-UAEC in vitro so we can directly measure the ion movements and associated changes in membrane potential that contribute to the [Ca2+]i burst response to ATP. In particular we will work to identify a role for SK or IK channels during [Ca2+]i burst events (identified by simultaneous Fura imaging) and further investigate the ability of NS309 to potentiate opening of TRPC3 channels even in the face of VEGF165 inhibited CX43 communication. We will use freshly isolated vessels (UA Endo) ex vivo to relate these findings to UA endothelial NO production, and finally examine corresponding effects on UA vasodilation of flow in vivo. We will thus establish the utility of a completely new therapy KCa channel therapy to support pregnancy enhanced vasodilation that is otherwise lacking in PE subjects. Our Specific Aims are: " Aim 1 [in Vitro]: To determine the electrophysiologic changes in the plasma membrane of NP- and P- UAEC as they relate to overall [Ca2+]i burst activity and determine the identity (SK vs IK) and relative role of channel activation in the basal and ATP- stimulated state. To further establish the ability of the SK and IK agonist NS309 to potentiate these responses in vitro in NP-, P- and VEGF treated P- UAEC. " Aim 2 [Ex Vivo]: To further establish the importance of SK and IK channel activation in controlling membrane potential, [Ca2+]i elevation and NO production in intact endothelium of NP- and P-UA Endo ex vivo. To further test the ability of the SK / IK agonist NS309 to potentiate these responses in NP- and P- UA Endo ex vivo, and in P-UA Endo after VEGF pretreatment (in anticipation of Aim 3). " Aim 3 [In Vivo]: To further compare in vivo the ability of ATP and the SK and IK agonist NS309 to potentiate uterine blood flow in an NO dependent manner. To further establish the importance of SK and IK channel activation in such control of uterine vascular flow in vivo.